Cellular and molecular determinants of an injury-associated capillary endothelial cell state during acute lung injury and regeneration

PROJECT SUMMARY/ABSTRACT
This proposal describes a five-year training plan for the development of an independent research career focused
on studying how endothelial immune signaling affects the lung’s response to viral injury. The applicant strives to
understand how endothelial cells coordinate immune responses early after influenza infection and how a novel
population of injury-associated capillary endothelial cells is regulated at sites of persistent lung injury late after
infection. The applicant is a Postdoctoral Fellow of Medicine in the Division of Pulmonary, Allergy and Critical
Care at the University of Pennsylvania. He has PhD training in molecular microbiology with a focus on using
bioinformatic approaches to understand how populations of cells interact with the adaptive immune system. The
goals of this award are for the applicant to gain additional expertise that will help him pursue a career as an
independent investigator with a focus on endothelial-immune interactions. The mentor for this award is Dr.
Edward Morrisey, an internationally recognized leader in lung regeneration with an outstanding training record.
An advisory committee comprising scientists with expertise in domains related to this proposal will support the
goals articulated in the training plan. The applicant will benefit from the unreserved support of his institution as
well as the unparalleled mentoring, resources, and scientific community at the University of Pennsylvania.
The applicant’s preliminary data define how the pulmonary endothelium responds to influenza infection by
upregulating genes involved in immune responses. After resolution of the infection, a novel population of capillary
endothelial cells is observed adjacent to immune cells in sites of persistent injury, exhibiting increased expression
of genes involved in immune signaling. The proposed studies will address the hypothesis that pulmonary
endothelial cells coordinate the early antiviral immune response and are maintained in an aberrant inflammatory
state late after infection at sites of dysplastic tissue repair. This will be accomplished through experiments in two
Specific Aims incorporating mouse genetic knockout models, lineage tracing, immunofluorescence imaging, and
spatial transcriptional profiling.The first aim seeks to define the role of two important immune signaling pathways
that are expressed in lung endothelial cells and upregulated during inflammation. The second aim investigates
the molecular and cellular pathways that give rise to and sustain inflamed capillary endothelial cells late after
lung injury. The applicant has established a career development plan that complements his current strengths
with additional training in immunology, physiologic measurements of lung disease, and advanced bioinformatics.
These training goals will be integrated with professional development activities, additional coursework, and input
from his Advisory Committee to help the applicant establish an independent basic science research program
focused on endothelial-immune signaling in viral injury and lung regeneration. This work addresses a needed
area of investigation and has a high potential for therapeutic impact in patients recovering from lung injury.

Public health relevance
PROJECT NARRATIVE After a severe viral infection there are areas of the lung that never heal properly and do not allow oxygen to enter the body normally. We have identified a group of lung capillary cells that remain inflamed for up to a year after influenza infection, in parts of the lung that remain damaged. We hope that studying how these cells develop and how they relate to immune and inflammatory responses will help identify new ways to promote healing of chronic lung damage after a viral infection.